LncRNA regulation of Type I IFN signaling in intestinal epithelium

Summary
Epithelial cells along the mucosal surface provide the front line of host defense against pathogen infection in
the gastrointestinal (GI) tract. These epithelial cells represent an integral component of a highly regulated
communication network that can transmit essential signals to cells in the underlying GI mucosa that, in turn,
serve as targets of mucosal immune mediators. How intestinal epithelial cells orchestrate GI mucosal
defense is still not fully understood. LncRNAs are recently identified long non-coding transcripts that can
regulate gene transcription through their interactions with other effect molecules. We have recently identified
a panel of lncRNAs that are upregulated in GI epithelial cells following microbial challenge. Specific lncRNAs
display a significant suppressive effect on Type I interferon (IFN)-controlled gene transcription in GI epithelial
cells. Interestingly, induction of some lncRNAs is controlled by Type I IFN signaling. Given the emerging
significance of lncRNAs in regulation of both innate and adaptive immune responses, coupled with the key
role of Type I IFN signaling in regulating GI homeostasis, we speculate that lncRNAs may be important
regulators in GI physiology and pathophysiology. In this study, we hypothesize that lncRNAs provide
negative feedback regulation of Type I IFN signaling through suppression of Type I IFN-controlled gene
transcription, consequently contributing to fine-tuning of epithelial cell innate defense against microbial
infection. We will use in vitro, ex vivo and in vivo infection models and complementary biochemical,
molecular, and morphologic approaches to elucidate the molecular mechanisms by which lncRNAs modulate
Type I IFN-mediated gene transcription in GI epithelial cells (Aim 1) and determine the role of lncRNA-
mediated feedback regulation of Type I IFN-mediated gene transcription in GI epithelial innate defense (Aim
2). Therefore, this application will explore a novel mechanism for lncRNAs in regulating GI mucosal innate
immunity. Elucidating the regulation of key signal pathways in GI epithelial cells by lncRNAs may reveal new
insights into the molecular immunology and immunopathology of the GI tract.

Public health relevance
Health Relevance The proposed research will study the role of lncRNAs in regulating GI epithelial immune responses. The outcome will establish a foundation on which to build new, long-term mechanistic studies to define how intestinal epithelial cells orchestrate GI mucosal immunity, providing a basis for future development of novel therapeutic strategies targeting these mechanisms.